Understanding Modulation of Neuronal Subpopulations by Sympathetic Glia

PROPOSAL
ABSTRACT OF FUNDED GRANT
Cardiac injury predisposes patients to heart failure (HF), and ventricular
tachycardia/fibrillation (VT/VF). Development of HF and VT/VF after cardiac injury is tightly
linked to sympathetic neural remodeling. Although several medications targeting cardiac
sympathetic excess reduce mortality following cardiac injury, significant shortcomings of these
drugs include off-target effects, limited efficacy, and focus on downstream consequences of
neural remodeling such as excess catecholamine release, rather than preventing it upstream. In
this proposal, we build on strong preliminary data from humans, porcine, and murine models
demonstrating that satellite glial cell (SGC) activation is a central feature of chronic cardiac
injury. Activated glia release inflammatory cytokines, ATP, and other factors that modulate
neuronal function. Chemogenetic upregulation of glial calcium signaling (as observed in
activated glia) increase cardiac sympathetic neuronal excitability, synaptic efficacy, and tonic
firing. Based on these novel findings, the goal of this proposal is to test the hypothesis that
satellite glial activation and enhanced glial-neuronal signaling is a primary driver of cardiac
sympathetic neuronal dysfunction, HF and VT/VF after cardiac injury. We will test our
hypotheses using novel tools from a multidisciplinary team of investigators in 3 specific aims in
two murine models of cardiac injury (ischemia-reperfusion and dilated cardiomyopathy). We will
test whether following cardiac injury, satellite glial cell activation within stellate ganglia
exacerbates neuronal and cardiac remodeling (structural and functional) to promote LV
dysfunction and VT/VF (Aim 1). We will investigate the mechanisms by which cardiac injury
activates SGCs in stellate ganglia after injury (Aim 2). Finally, we will determine whether
targeting glial Gq-GPCR Ca2+ signaling or Cx43-mediated glia-neuron/glial- glial
communication mitigates adverse remodeling and arrhythmogenesis following cardiac injury
(Aim 3). The results of this proposal will 1) indicate whether and how satellite glial cell activation
contributes to sympathetic imbalance after cardiac injury; and 2) determine whether targeting
satellite glial cell activation offers therapeutic potential in chronic cardiac injury.

Public health relevance
Project narrative: Chronic cardiac injury results in persistent sympathoexcitation, which predisposes patients to ventricular arrhythmias, a leading cause of death worldwide. The proposed research aims to investigate the structural and functional characterization of an identified population of cardiac sympathetic neurons (neuropeptide Y2 receptor-expressing neurons (NPY2R)) that exert potent sympathetic effects on the heart. In this study, we will investigate NPY2R neurons as a selective target in minimizing excessive sympathetic drive to the heart, presenting a potential therapeutic avenue for chronic cardiac injury.